New epigenetic inhibitors for Alzheimer's disease treatment

Project Summary
Alzheimer’s disease (AD) is a neurodegenerative disorder that is the primary cause of dementia, the mechanisms
of AD have not been completely elucidated and there has yet to yield effective therapy that can prevent, stop or
reverse cognitive deficits associated with AD. Epigenetics refers to functional modifications to the genome that
do not involve a change in the DNA sequence. Epigenetics became an attractive field in recent years within the
drug discovery research communities. Recent preclinical studies also provide robust evidence for the
involvement of HDACs in various neurological diseases, and pharmacological treatment aimed at modulating
epigenetic regulation. The goal of this application is to develop novel small molecules as HDAC11 selective
inhibitor as potential AD therapeutics. In this proposal, we will explore SAR of our leading scaffold to develop a
new generation of HDAC11-selective inhibitors (Aim 1), which will be tested to select top compounds with
improved PK/PD properties and anti-AD effects using AD preclinical models (Aim 2). Towards the ultimate goal
of developing novel HDAC11 inhibitors as effective AD treatments, the end-point of this application is to identify
top candidates for Investigational New Drug (IND)-enabling studies.

Public health relevance
Project Narrative HDACs are a key epigenetic enzymes involved in Alzheimer’s disease (AD). This proposal aims to develop novel HDAC11 selective inhibitors and perform evaluation in AD cells and models.